Mechanisms of Fecal Microbiota Transplant Protection from Recurrent C. difficile

Project Summary
Introduction: Recurrent C. difficile infection (rCDI) occurs in one of every five patients infected. The most
effective therapy is fecal microbiota transplant (FMT). Here we propose to understand how FMT acts to protect
patients with rCDI through colon biopsies pre- and post-FMT, and through mouse models of FMT.
Hypothesis: FMT prevents recurrent CDI (rCDI) by: (1) decreasing SNS signaling via α2AR; (2) activating
ILC2; and (3) mediating intestinal epithelial proliferation and repair via EGFR.
Significance: Successful completion of the work will identify mechanisms of action of FMT, which is the most
effective therapy for rCDI, and will lay the foundation for therapy for rCDI targeting the SNS, immune system and/or
EGFR as an adjunct and/or replacement for FMT. In addition the work has potential applications in other diseases
where FMT is being applied including inflammatory bowel disease and cancer checkpoint inhibitor resistance.
Investigators: The MPIs William Petri and Girija Ramakrishnan have collaborated and co-published for over 25
years and together have set the stage for the proposed studies through a clinical study of humans undergoing
FMT for rCDI, and through mechanisms of action studies of CDI and FMT in mouse models.
Innovation: The hypothesis is innovative as it challenges, by its exploration of FMT impact on the host, the
existing paradigm that FMT acts predominantly by its impact on the pathogen C. difficile. Innovative
approaches include the longitudinal study of subjects undergoing FMT for rCDI, transgenic mouse models to
probe the actions of the SNS, ILC and EGFR in rCDI and FMT, and innovative techniques including spatial
transcriptomics and scRNAseq of the colon.
Progress over the last 5 years of funding: Includes the discoveries that the TNFα and IL-8 response to CDI in
the mouse model is initiated by a2AR activation; that IL-33 acts via ILC2 in mice to block Th17 and promote
anti-TcdB antibody production; and that in humans FMT increased amphiregulin, crypt depth and Myc and
mTOR signaling. There have been 15 peer-reviewed original research papers, 3 preprints, and 3 reviews over
the 5-year funding period supported by 5R01AI152477 and two patent filings.
Approach: In each Aim a mouse model of FMT will be compared to humans undergoing FMT.
Speciﬁc Aim 1: Test if FMT prevents CDI damage by downregulating the SNS.
Speciﬁc Aim 2: Test if FMT decreases inflammation by activating ILC2
Speciﬁc Aim 3: Test if FMT repairs the gut via EGFR
Environment: The University of Virginia Division of Infectious Diseases and Beirne Carter Immunology Center
provide a rich intellectual environment in the Carter-Harrison Medical Research Building where the work will be
conducted.

Public health relevance
Narrative Clostridioides difficile infection (CDI) is the most common hospital-acquired infection in the US, with one in five patients with CDI suffering a recurrence. We have identified three key steps in fecal microbiota transplantation (FMT) protection from C. difficile colitis that may serve as sites for therapeutic intervention: (1) Inflammation due to C. difficile is blocked by prevention of sympathetic nervous system activation of the α2 adrenergic receptor; (2) FMT acts via Innate Lymphoid Cells 2 (ILC2) to orchestrate a protective type 2 immune response; and (3) FMT activates EGF receptor pathways and intestinal epithelial proliferation. We propose here to better understand these steps in FMT-mediated protection, with the goal to provide novel therapeutic approaches to C. difficile colitis prevention and management.